Progenitor Cell Dysfunction and Impaired Neovascularization in Diabetes

Project Summary Diabetes affects recovery from ischemic insult by blunting the neovascular response. Ischemic neovascularization occurs via two fundamentally different pathways: the sprouting of new blood vessels from existing vessels (angiogenesis), and the recruitment, proliferation, and assembly of bone marrow-derived progenitor cells into new vessels (vasculogenesis). Our work over the last four years has shown that diabetes impairs new blood vessel formation in response to hypoxia by causing abnormal ischemia-induced signaling as well as impaired progenitor cell proliferation, function, and trafficking. We have shown that these derangements in progenitor cells are caused by reactive oxygen species (ROS), which reduce the number and function of bone marrow-derived mesenchymal stem cells (MSCs) and endothelial progenitor cells (EPCs). We have also seen ROS-induced changes in hematopoietic stem cells. Normalizing blood glucose does not reverse these effects, which may contribute to the phenomenon known as hyperglycemic memory. It is our fundamental hypothesis that diabetes-induced derangements in progenitor cell biology underlie the observed impairments in ischemia-induced neovascularization. In this proposal, we will determine how bone marrow-derived mesenchymal stem cells contribute to the development of new blood vessels in the setting of hypoxia (SA1), examine the how hyperglycemia alters these progenitor cell populations, including MSCs and HSCs (SA2), and clarify how hyperglycemia-induced ROS alters pathways affecting cell cycle progression and decreased stem cell capacity in HSCs and MSCs (SA3). Finally, to determine the clinical relevance of our findings, we will examine human circulating EPCs, bone marrow-derived HSCs, and bone marrow-derived MSCs from non-diabetic and diabetic patients (SA4).

Public health relevance
Principal Investigator/Program Director (Last, First, Middle): Gurtner, Geoffrey, Cash Project Narrative Diabetes is a major public health concern in the United States, accounting for 180 billion dollars in annual health costs. Diabetes-induced impairments in new blood vessel growth greatly increase the severity of the sequelae caused by various ischemic processes, including coronary artery disease, cerebrovascular disease, peripheral vascular disease and impaired wound healing. Recovery from ischemic injury requires new blood vessel growth, termed neovascularization.